GlyCORE: Glycoscience Center of Research Excellence

Project Summary
Understanding tissue healing and protein expression after injury is crucial in regenerative medicine. The
glycoprotein CTHRC1 plays a vital role in tissue repair, regulation of fat cell formation, and bone development.
It is produced by activated fibroblasts and contributes to metabolic efficiency and the survival of endothelial cells,
which maintain homeostasis and capillary networks during healing. However, abnormal CTHRC1 expression is
observed in chronic inflammation as well as malignant growth. While glycosylation is essential for the proper
functioning of many secreted proteins, we don't yet understand how glycosylation impacts the beneficial effects
of CTHRC1. CTHRC1 is a secreted protein with a 16-amino acid pro-peptide at its N-terminus. Removing this
pro-peptide increases the biological activity of the protein. Our recent findings indicate that both the full-length
and truncated forms of CTHRC1 promote glycolysis in endothelial cells, with the truncated form being particularly
potent. Even though these initial structure–activity observations highlight the importance of protein modifications
in controlling activity of CTHRC1, no further studies exploring the relationship between structure and function of
CTHRC1 have been conducted. Additionally, the specific receptor for CTHRC1 remains unknown. In this
collaborative project, our goal is to investigate how glycosylation of CTHRC1 influences its binding to target cells
and its role in regulating energy metabolism. We will also track the cellular localization of internalized CTHRC1
by chemically tagging different amino acid residues to elucidate its site of action. Understanding the pro-glycolytic
effects of CTHRC1 is instrumental in comprehending the functioning of endothelial cells during ongoing tissue
repair. This proposal aims to develop CTHRC1 into a valuable tool to better understand the characteristics of
activated endothelial cells during wound healing. To accomplish this objective, we will adopt an interdisciplinary
team-science approach that builds upon the expertise and resources of the Centers for Biomedical Research
Excellence (COBRE) supported by NIGMS in Mississippi and Maine. By leveraging state-of-the-art glycoscience
techniques, we aim to address the challenges faced in the field of regenerative medicine.

Public health relevance
Project Narrative The University of Mississippi proposes to establish the Glycoscience Center of Research Excellence (GlyCORE), a new University-wide center to study how carbohydrates and carbohydrate-containing molecules affect human health. GlyCORE will support investigators in glycoscience through direct funding of selected research projects, establish mentors for early career investigators, support the recruitment of new faculty in glycoscience, and develop local and regional meetings for investigators to discuss their work. GlyCORE will also support the establishment of three central research cores to support these investigators with cutting-edge biomedical research tools.